Association between pre-diagnosis hepatic fat infiltration and risk of liver metastasis and mortality in a large cohort of stage I-III colorectal cancer survivors

PROJECT SUMMARY/ABSTRACT
Development of liver metastases among stage I-III colorectal cancer (CRC) patients following resection
suggests the presence of clinically undetectable liver micro-metastases prior to CRC diagnosis. Non-
alcoholic fatty liver disease (NAFLD) is quickly emerging as the most common liver disease worldwide with
an estimated prevalence of 20-30% in the U.S. population. To date, various lines of evidence support our
hypothesis of the potential role of liver fat in enhancing CRC liver metastasis; the next step is to
demonstrate the utility of quantitative assessment of hepatic fat as a prognostic biomarker for stage I-III
CRC patients in clinical settings. Almost all CRC patients in the U.S. get a computerized tomography (CT)
scan at diagnosis, and NAFLD is a highly prevalent and treatable disease, thus, if our hypothesis is
confirmed, we hope to establish a safe and cost-efficient prognostic biomarker, which is currently lacking.
The recently expanded C-SCANS (CRC-Sarcopenia and Near-term Survival) cohort was derived from the
Kaiser Permanente Northern California cancer registry, with ascertainment of patients with stage I-III CRC
diagnosed between 2006 and 2018, aged 18−80 years, who underwent surgical resection. Inclusion criteria
include that patients had baseline CT images within 4 months of diagnosis, and prior to treatment.
In Aim 1,
hepatic fat (quantitative assessment) will be measured in CT scans performed at time of CRC diagnosis,
and prior to treatment. First, measurements will be performed manually, and then using a novel machine
learning-based tool for liver segmentation, and measurement of liver and spleen attenuation. In Aims 2 and
3, we will examine (a) whether increased hepatic fat infiltration is associated with higher risk of liver
metastases, recurrence, and CRC mortality, and (b) whether associations are modified by comorbidities
and risk factors related to the metabolic syndrome. In Aim 4, we will examine whether hepatic fat affects
liver metastases through a direct and/or indirect effect (e.g., mediated through the metabolic syndrome).
Specifically, we hypothesize that the direct effect of hepatic fat is more important in explaining the
relationship between hepatic fat and liver metastases than the indirect effect. Data on body composition,
including
skeletal muscle and total, subcutaneous and visceral fat, and hepatic fat for each patient are
measured on the same CT scans, which combined with assessment of behavioral risk factors, clinical data,
and metabolic plasma markers around the same time , provide an unprecedented opportunity to rigorously
study these effects. Thus, this cost-efficient and innovative application will address the urgent need for
more accurate prognostic biomarkers and relatively safe interventions to improve prognosis in stage I to III
CRC patients. Considering the alarming rise in prevalence of NAFLD, this application has the potential to
reduce morbidity and mortality in a substantial number of stage I-III CRC patients.

Public health relevance
PROJECT NARRATIVE We propose to conduct a comprehensive study on the relationship between hepatic fat infiltration and risk of liver metastases. This study will help to establish a safe and cost-efficient prognostic biomarker for stage I-III CRC patients, and provide the scientific foundation for future exploration into behavioral and pharmacological interventions, specifically targeting high hepatic fat infiltration. Considering the alarming rise in prevalence of non-alcoholic fatty liver disease in the U.S. and globally, these interventions may help to reduce morbidity and mortality in a substantial number of stage I-III CRC patients.